RR&D Research Career Scientist Award Application

Project Summary / Abstract
The current VA-funded research activities of the nominee fall into two major categories: studies of the
chronic effects of TBI and studies of the non-motor symptoms of Parkinson's disease. With regard to TBI,
current studies in the nominee's lab are focusing on the most prevalent form of TBI seen in military personnel,
Veterans and civilians- repetitive, mild TBI (rmTBI). This insidious form of head injury has many comorbid
psychiatric, cognitive, sleep and behavioral abnormalities associated with it yet it remains poorly understood
and effective treatments for it are not available. The lab of the nominee recently developed a new animal
model of rmTBI that has opened new avenues of investigation into the chronic outcomes of head injury. Initial
work has established that the model can be used to deliver numerous impacts to the head of a mouse without
causing skull fracture, intracranial bleeding or paralysis. However, this model is unique in that it results in many
of the long-term outcomes that are being seen in Veterans and athletes to include depression- and anxiety-like
affective disorders, sleep disturbances, cognitive decline and a CTE-like neuropathology. Another unique
element this line of research is the testing of a new therapy for rmTBI. To date, all clinical tests of TBI therapies
have failed and the possibility must be considered that the reason for this 100% failure rate is related to the
use of animal models of TBI that do not faithfully create impact conditions to which humans are exposed. Our
new model of rmTBI fills this gap. Soon after publication of our new model, we were approached by Acetylon
Pharmaceuticals to test their new HDAC6 inhibitor as a therapy for rmTBI. Studies underway with this new
compound are producing promising results and emerging tests will also determine its effectiveness in relieving
the comorbid conditions that often accompany rmTBI.
With regard to Parkinson's disease (PD), it is becoming that the non-motor symptoms (NMS) of this
neurodegenerative disease lower the quality of life for Veterans more so than the much better understood
motor symptoms. The NMS of Parkinson's can include many of the same conditions cited above for rmTBI. To
date, the vast majority of preclinical and clinical studies of PD have focused on the dopamine (DA) neuronal
system and how its destruction can result in disease symptomology. Most therapies for PD also target the DA
system. As is the case for rmTBI, there is no effective therapy for the NMS of PD. However, while vastly
underappreciated, the serotonin (5HT) and norepinephrine (NE) systems are also extensively altered in PD.
The lab of the nominee has created two genetically modified mouse strains that lack brain 5HT. One is a
constitutive null mutation in the gene for tryptophan hydroxylase and a new strain is a tamoxifen-inducible
knockout of the same gene. The key facet that makes these mouse strains so applicable to the study of the
NMS of PD is the fact that the 5HT deficits in them are very similar to those now known to occur in humans
with PD- loss of function without degeneration of 5HT neurons. These 5HT deficient mice will be used to create
combined monoamine deficits using neurotoxins that selectively target the DA (MPTP) and the NE (DPS-4)
neuronal systems and the effects of these alterations on the emergence of NMS will be assessed. These
studies will also test the natural precursors of each monoamine alone or in combination to restore function and
alleviate the NMS.
The overarching goal of the above described research is to improve the treatment and enhance the
rehabilitation of Veterans afflicted with rmTBI and PD. This goal is extremely important because these two
disorders affect a very large number of Veterans and each is frequently associated with numerous, additional
comorbid disorders. Our overarching goal will be achieved by increasing the understanding of the disease
mechanisms of rmTBI and PD NMS via the application of new and innovative technical approaches and
through the testing of novel, rational and safe therapeutic approaches.

Public health relevance
Project Narrative A disproportionate number of Veterans are afflicted by health conditions associated with or acquired through their military service. These include traumatic brain injury and Parkinson's disease. Currently, effective treatments or rehabilitative therapies are available for these conditions. The problem is compounded by the fact that traumatic brain injury and Parkinson's disease are each often accompanied by numerous, serious comorbid disorders. The research program of the Nominee is aimed at achieving a better understanding of the disease mechanisms associated with traumatic brain injury and Parkinson's disease. Through this work, new and innovative technical approaches will be employed to test novel and safe rehabilitative approaches that can be used to improve the standard of care for our Veterans who suffer from the outcomes of traumatic brain injury and Parkinson's disease. For these reasons, the ongoing program of research of the Nominee is highly relevant to Veteran's health and/or health care issues as well as the research priorities of the RR&D Service.